Regulation of Plasmodium-specific CD4+ T cells

PROJECT SUMMARY
Plasmodium infections and the disease malaria remain global health emergencies. Plasmodium parasites
replicate within and cause the destruction of host red blood cells, which triggers inflammation and causes the
symptoms of malarial disease. Parasite-specific antibody responses that develop following infection are critical
for controlling parasite burden and limiting disease severity. CD4+ helper T cells are essential for coordinating
these protective antibody responses. However, sterilizing anti-Plasmodium immunity rarely develops, even
following repeated infection. We hypothesize immune failures are mechanistically linked to aberrant or inefficient
Plasmodium-specific effector CD4+ T cell development and function. One of the most critical challenges to
developing new immune-based therapies or vaccines against Plasmodium is understanding the mechanisms by
which Plasmodium-specific CD4+ T cells develop, function and regulate humoral immunity following infection.
In the continuation of this project, we apply powerful new cellular and molecular genetic approaches that
enable direct, high-resolution analyses of Plasmodium-specific CD4+ T cells. These new approaches facilitate
our long-term goal to understand the mechanisms governing the development and function of Plasmodium-
specific CD4+ T cell responses. Our goal is addressed by two specific aims that have evolved to test: 1) how
parasite-derived molecules influence cell antigen presenting functions and priming of Plasmodium-specific CD4+
T populations; and 2) how host physiological perturbations and constraints on cellular metabolism regulate CD4+
T cell development and function. Our innovative conceptual and technical advances and mechanistic approaches
enable us to establish additional new paradigms for understanding and enhancing CD4+ T cell-dependent anti-
Plasmodium immunity. Understanding cellular and molecular events governing CD4 T+ T cell responses during
malaria will enable us to identify and develop new immune-based strategies to limit Plasmodium pathogenesis
and disease burden.

Public health relevance
PROJECT NARRATIVE Plasmodium infections cause more than 400 million cases of malaria each year and more than 3.5 billion people are at risk for contracting this devastating infectious disease. The goal of our research is to identify and develop new immune-based interventions that improve the function of cells that are critical for resistance to blood-stage Plasmodium infection. These studies will enable us to enhance immunity against malaria.